Electronic Nicotine Delivery Systems (ENDS) Use and Access in Florida's Tobacco Regulatory Environment

PROJECT ABSTRACT
While cigarette smoking and smokeless tobacco use has declined among American youth over time, use of
electronic cigarettes – or vaping – among youth has increased tremendously. The recent vaping-related acute
lung injuries and deaths as well as the first animal studies linking vaping to cancer have highlighted the need to
respond to e-cigarette use among youth.
In Aim 1, the project will assess the relationship between spatial density and proximity of tobacco/e-cigarette
retailers around schools and county-level youth e-cigarette use and marketing exposure in Florida, overall and
by county-level sociodemographic characteristics and racial/ethnic segregation. In Aim 2, it will qualitatively
explore where, how, why, and from whom youth access e-cigarettes, interactions with tobacco/e-cigarette
retailers, exposure to e-cigarette marketing, and combined substance use, as well as whether these factors differ
across neighborhood sociodemographic characteristics using participatory mapping and focus groups. Finally,
in Aim 3, I will leverage a natural experiment in tobacco regulation across three Florida counties to assess
whether T21+TRL is more effective in reducing youth ENDS use and marketing exposure than T21 alone using
quasi-experimental methods – comparative interrupted time series and difference-in-differences analysis.
Dr. Zinzi Bailey is an Assistant Scientist in the Jay Weiss Institute for Health Equity at the Sylvester
Comprehensive Cancer Center at the University of Miami Miller School of Medicine. As a Black woman in
academia where Black women are underrepresented, Dr. Bailey seeks a K01 Mentored Research Scientist
Development Award to Promote Diversity to gain the skills, experience, and preliminary data needed for an
independent, policy-focused research program in translational cancer disparities research. Dr. Bailey will
integrate her background in social epidemiology and tobacco smoking behavior with methods and theories that
capture the socio-ecological complexity of tobacco regulation and its potential impact across communities.
To achieve this goal, Dr. Bailey proposes to gain the training and experience in policy analysis using quasi-
experimental designs, geographic information systems, and participatory research through mentorship,
coursework, workshops/seminars, and scientific meetings. Her career development objectives include (1)
obtaining training in quasi-experimental designs for policy analysis, (2) advancing my expertise in assessing
local, state, and federal tobacco policies and regulations, (3) receiving formal policy-relevant training in
geographic information systems (GIS) and spatial econometrics, and (4) developing methodological training on
qualitative, participatory methods.
This study will lay the groundwork for a tobacco regulation-oriented research program that blends multiple
methods of policy analysis to guide the translation of disparities-focused research to evidence-based policy.

Public health relevance
PROJECT NARRATIVE The recent vaping-related acute lung injuries and deaths as well as the first animal studies linking vaping to cancer have highlighted the need to respond to e-cigarette use among youth. This study will assess the relationship between e-cigarette retailer access and youth e-cigarette use, access, and exposure to marketing in Florida, explore where, how, why, and from whom youth access e-cigarettes, and whether combined tobacco regulations will reduce youth e-cigarette use and marketing exposure. It will also lay the groundwork for a tobacco regulation-oriented research program that blends multiple methods of policy analysis to guide the translation of disparities-focused research to evidence-based policy.